HAZMAT Training at DOE Nuclear Weapons Complex (UH4 Clinical Trial Not Allowed)

CPWR DOE HAZMAT Summary/Abstract
This application is being submitted by CPWR-The Center for Construction Research and Training (CPWR) in
response to the Funding Opportunity Announcement, RFA-ES-24-002, HAZMAT Training at DOE Nuclear
Weapons Complex (UH4), for a Cooperative Agreement to support the development of model programs for the
training and education of workers engaged in activities related to hazardous waste generation, removal,
containment, transportation and emergency response within the Department of Energy (DOE) Nuclear
Weapons Complex.
CPWR is the 501(c)(3) non-profit construction safety and health research and training arm of the North
America's Building Trades Unions (NABTU), which represents 14 international/national building trades unions
and over 3 million workers. CPWR submits this application in coordination and cooperation with a training
consortium of 13 international/national building trades unions representing workers employed primarily by
contractors and sub-contractors working throughout DOE's nuclear weapons complex.
Our proposed program is national in scope, and our major objective is to prevent work-related harm by training
construction workers on DOE sites how best to protect themselves and their communities from exposure to
hazardous materials encountered during hazardous waste operations, facility decommissioning and
decontamination, hazardous materials transportation, environmental restoration of contaminated facilities or
chemical emergency response. In partnership with our 13 building trades union training consortium, our
specific aims are: 1) train 10,146 students in 768 courses in Year 1 and 50,730 students in 3,840 courses over
five years; 2) continue rigorous evaluations of all training courses, to assess students, instructors, curriculum,
and outcomes; 3) conduct train-the-trainer programs to continue to grow the pool of trainers available across
the United States; and 4) continue training and education for new and current instructors.

Public health relevance
Project Narrative The relevance of this proposal, which is national in scope, is to prevent work-related fatalities, injuries and illnesses by training construction workers on DOE sites how best to protect themselves, their workplaces and their communities from exposure to radiation and other hazardous materials encountered during hazardous waste operations, facility decommissioning, decontamination and demolition, hazardous materials transportation, environmental restoration of contaminated facilities or chemical emergency response. A well trained construction workforce enables DOE, its contractors and subcontractors, and other stakeholders, such as trade unions and Native American tribes, protect not only the workers themselves but communities surrounding DOE sites.